Computational tools for illuminating the dark matter of the human virome

Project Summary
As greater understanding of the important role that the human microbiome plays in human
health has unfolded it is increasingly recognized that there is a vast and uncharted group of
viruses that have direct and important inﬂuence on the composi�on, dynamics, and func�on of
these microbial communi�es, and thus on the health of the human host. Metagenome
sequencing eﬀorts and other high-throughput methodologies have opened the door to large-
scale cataloguing and characteriza�on of free-living viruses and prophage, which are resident in
their bacterial host genomes. However, the diversity and lack of knowledge about these viruses
hampers our ability to understand their poten�al impact. Illumina�ng the region outside of our
current knowledge, so-called ‘dark mater’, is necessary to be able to understand, monitor,
control, and u�lize virus-community interac�ons to promote human health.
We hypothesize that applica�on of established and newly developed pipelines using these and
other tools will allow vastly improved iden�ﬁca�on and characteriza�on of viral elements that
are impac�ng human microbiome dynamics, and that providing improved tools for visualizing
these predic�ons and the rela�onships between them will have a broad impact on the ﬁeld. To
address these gaps we will develop enhanced methods for detec�on of viral sequences using
graph assemblies, build a sequence- and structure-based pipeline for characteriza�on of
auxiliary genes carried by viruses, and provide novel and useful ways of visualizing this complex
informa�on to allow greater insight from researchers in the ﬁeld.

Public health relevance
Project Narra�ve This project will help understand the impact of bacteriophage, viruses infec�ng bacteria, on human health by developing new computa�onal tools to understand the func�on of these viruses. The results of this project could illuminate causes of diseases that are linked to the microbiome and help provide therapies for treatment of the microbiome to enhance health.